Allergen T cell epitopes and phenotypes in peanut allergy and immunotherapy

Summary for Overview
The proposed Center will perform mechanistic studies of allergen-specific T cell responses in peanut allergic
subjects through two synergistic projects. The first project will investigate the phenotypic and functional
characteristics of allergen specific T cells in subjects with peanut allergy and subjects that are tolerant to
peanut. The second project will investigate changes in the frequency, phenotype, and function of allergen-
specific T cells that are associated with immunotherapy. This project will utilize longitudinal clinical samples
from a peanut oral immunotherapy trial and samples from a peanut peptide immunotherapy in which subjects
will receive intradermal injection of the peanut peptide vaccine. Both projects will utilize cutting edge
technologies including metal tag class II tetramer reagents with CyTOF and single cell RNA-seq to study
peanut allergen specific T cells. The infrastructure of our Center includes two cores. Core A, the Administrative
Core, will oversee scientific progress of the two projects, facilitate data integration between the projects, and
provide managerial responsibility and fiscal management for the Center. Core B, the Gene Expression and
Systems Immunology Core will be responsible for data analysis for RNA-seq, Flow Cytometry and Mass
Cytometry, and will also work with Core A in data management. Benaroya Research Institute has state-of-the-
art facilities and technical equipment, established infrastructure for technical support and subject recruitment,
and collegial environments to support the research as propose.

Public health relevance
Project Narrative for Overview The overall aim of this center is to understand the role of peanut epitope-specific T-cell responses in the pathogenesis and treatment of peanut allergy by utilizing peanut T cell epitope-specific tetramer reagents and other novel assays. New knowledge gained in this proposal should facilitate the practice of precision medicine and the development of novel intervention in treating subjects with peanut allergy.